Sulfated Carbohydrates for the Treatment of Periodontitis

Abstract
Periodontitis affects over half of the American population and has no reliable form of treatment for any stage and grade of
the disease besides antibiotics, tooth root scaling and planing and periodontal surgery with highly variable outcomes. This
STTR application proposes to identify a structurally defined sulfated low molecular weight heparan sulfate as a novel
therapeutic for treatment of periodontitis. Glycan Therapeutics LLC is a company specialized in synthesizing sulfated
carbohydrates using innovative enzyme-based methods and produce large quantities of several carbohydrates currently
being explored for biological use. One of the molecules, an 18-mer sulfated heparan sulfate, has been reported to be anti-
inflammatory by our group and preliminary data shows a promising effect on promotion of bone homeostasis. This
proposal is focused on the investigation of a specifically sulfated 18-mer length carbohydrate as a periodontal therapeutic
in vitro and in vivo. Further, as the carbohydrate investigated proves to be both anti-inflammatory and bone anabolic in
nature, it will be investigated in the context of high risk and more severe and hyperinflammatory forms of periodontitis
such as in subjects with diabetes. The team consists of Dr. Patricia Miguez, clinician scientist, bone and extracellular
matrix biologist and periodontist, and collaborators at UNC-CH and Dr. Vijay Pagadala, co-investigator from Glycan
Therapeutics with significant experience in synthesis and characterization of such synthetic oligosaccharides. This
proposal will provide valuable insights into the mechanism of action of such small sulfated carbohydrates in bone
homeostasis, provide efficacy data in proof-of-concept studies in small animals and pave the way for a phase II proposal
to evaluate such therapeutic for treatment of periodontitis in a large animal model and with development of an efficient
and long-lasting intra-oral delivery system.

Public health relevance
Project Narrative Periodontitis is a chronic inflammatory disease of the supporting tissues around teeth leading to tooth loss and low quality of life. This disease affects about half of the American population and a therapeutic has not been found to effectively manage the disease with about 30% of cases having a refractory profile. Periodontal disease can be even more aggressive with presence of risk factors such as diabetes and has been associated with other systemic cardiovascular, renal and other health conditions. This proposal will focus on development of a synthetic small heparan sulfate with anti-inflammatory properties and potential bone anabolic function and evaluate its efficacy in treatment of periodontitis.